Psychedelic treatment to improve social and cognitive function in preclinical models of schizophrenia

Background and Innovation: Cognitive and social deficits in schizophrenia are extremely debilitating and
remain undertreated with current antipsychotic medications. Serotonergic psychedelics such as psilocybin and
entactogens such as MDMA have shown promise as therapeutics for neuropsychiatric disorders and are being
considered as adjunctive treatment for schizophrenia. Two of the proposed mechanisms for the therapeutic
benefit of psychedelics and entactogens are their ability to increase social connectedness and cognitive
flexibility, both of which are deficient in schizophrenia. Preclinical studies will help inform the field on the
receptor and circuit mechanisms of these serotonergic compounds for the treatment of social and cognitive
deficits in schizophrenia, and whether beneficial effects remain in the context of antipsychotic treatment. The
goals of the proposed studies are to (1) dissect the receptor and circuit mechanisms through which psilocybin
and MDMA improve cognitive flexibility and social motivation; and (2) examine their therapeutic efficacy in a
neurodevelopmental model relevant to schizophrenia and in the context of antipsychotics.
Significance and Impact to Veterans Healthcare: Veterans with schizophrenia are among the most ill of
those treated at VA facilities, which presents a great burden on care and VA resources. The inadequacy of
treatment response and myriad side effects of current medications makes long-term care and medication
adherence difficult. Hence, better treatment of Veterans with psychotic disorders will greatly improve their
overall quality of life and long-term care. These preclinical studies will help identify potential therapeutic targets
for future studies in Veterans.
Path to translation/implementation: If successful, the proposed studies will indicate whether acute
administration of psychedelics and entactogens can improve behaviors associated with schizophrenia.
Findings will inform clinicians on how these drugs may be working in the brain to alter behavior and whether or
not the drugs produce the expected effects in the context of antipsychotic treatment. To move the research
along the translational pathway, the next steps will be to use these preclinical studies to inform clinicians on the
dose and timing of psychedelic administration and their interaction with antipsychotic medications. New
therapeutic targets identified by these studies may lead to drug development for social and cognitive deficits in
Veterans with schizophrenia.

Public health relevance
Serious mental illnesses such as schizophrenia account for a large portion of inpatient care at the VA and current medications do not adequately treat symptoms. Developing new treatments for the debilitating cognitive and social deficits is imperative. Serotonergic psychedelics such as psilocybin and entactogens such as MDMA are being tested for therapeutic use in psychiatric disorders, including schizophrenia, due to their ability to increase social connectedness and cognitive flexibility, both of which are deficient in schizophrenia. Preclinical studies will help inform the field on the receptor and circuit mechanisms of these serotonergic compounds for the treatment of social and cognitive deficits in schizophrenia, and whether beneficial effects remain in the context of antipsychotic treatment. The proposed studies will focus on modulation of social behavior and cognitive flexibility in both normal animals and in a neurodevelopmental model (e.g. social isolation rearing) with deficits in both cognitive flexibility and social approach behavior.